Mechanisms of specification, quiescence, and regeneration of primordial germ cells

Project Summary
We request support through this administrative supplement mechanism for a chilled marine aquarium unit to
house our several echinoderm species, and our genetically manipulated adults derived from the experiments
proposed in the parent application. Our 16-year-old main marine aquarium unit has failed, and our work has
significantly expanded beyond its capacity and here we request support to replace it with a unit that will give us
functionality and expanded capacity. The research supported by this request is focused on understanding the
mechanisms of formation of primordial germ cells during embryogenesis, how they form during early
development, and how they regenerate when the originals are removed. Our work leverages embryos from a
sister group to chordates – the sea star and sea urchin. While not common organisms for biomedical research,
these echinoderms have many strategic benefits for revealing unique perspectives in the biology of germline
formation and regeneration. Millions of synchronous embryos from a single male/female cross allow
biochemical and metabolic analysis of the germline, the resultant embryos have ideal transparency for in vivo
longitudinal imaging, they develop rapidly, are easy to manipulate (single cell drop-mRNA-seq, optogenetics,
cell and tissue transplantations) and they are well suited to complementary gene perturbation approaches
(CRISPR/Cas9, morpholinoantisense oligonucleotides, MASO), and small molecule perturbations. The existing
deep genomic and reagent resources for these animals, coupled with their tractable experimental
characteristics, yields a unique system for understanding primordial germ cell biology with defined molecular
and morphological endpoints, in live embryos with longitudinal analysis, distinct metrics of quantitation, and
transgenerational evaluations.

Public health relevance
Project Narrative We request support through this administrative supplement mechanism for a chilled marine aquarium unit to house our several echinoderm species, and our genetically manipulated adults derived from the experiments proposed in the parent application. Our 16-year-old main marine aquarium unit has failed, and our work has significantly expanded beyond its capacity and here we request support to replace it with a unit that will give us functionality and expanded capacity. The research supported by this request is focused on understanding the mechanisms of formation of primordial germ cells during embryogenesis, a process essential for sexual reproduction in animals.